Core I: Latino Core

ABSTRACT – LATINO CORE
The overall goal of the Latino Core is to support high quality, cutting edge, research projects on the etiology,
pathogenesis, diagnosis, treatment, and prevention of Alzheimer’s disease and related dementias (ADRD) by
providing data and biospecimens from well-characterized, longitudinally followed Latinos who initially enroll
without dementia from the community. Latinos are at greater risk of ADRD than non-Latino Whites, but the field
has struggled to engage this population in clinical research. In response to the NAPA milestones on health
disparities/equity, our Latino Core will support studies that assess the epidemiology, and mechanistic pathways
of disparities in health burden of ADRD, and facilitate engagement, understanding, and partnership with our
diverse participants using culturally-tailored approaches and research efforts to understand and advance the
science of disparities. Despite the existence of large, productive studies that include Latinos, progress in the
field has been hampered by a critical lack of brain tissue from well characterized older Latinos without
dementia. Moreover, there is limited data regarding cognitive decline and transitions from normal aging to mild
cognitive impairment (MCI) and dementia among older Latinos; and few studies have examined blood
biomarker differences across race/ethnicity. Building on our history of success and experience working with
underserved communities, the Latino Core is poised to fill a critical gap in our knowledge base, and accelerate
research in health disparities by providing resources, including participants, clinical data, and ante- and
postmortem biospecimens to support a wide range of research studies – particularly those that historically
have had limited data from diverse groups (e.g., neuroimaging, genomics, epigenomics, proteomics, and
metabolomics).